The Impact of a Changing Health Care Delivery System on the Quality of Oncology Care - Administrative Supplement

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as
NOT-CA-23-044. The cancer care delivery system that frequently provides care that is not patient-centered,
evidence-based, or accessible to vulnerable populations. In recent years, there has also been increasing
consolidation among providers, which could have important implications for the quality of cancer care.
Under the parent R01, we are studying the implications of growing integration across providers for
patients with cancer. One key outcome we have considered is the impact of integration on the delivery of oral
oncolytics. Oral oncolytics are an increasingly important treatment modality, accounting for nearly half of
chemotherapy spending among patients enrolled in Medicare Fee-for-Service and Part D in 2019.
Nonetheless, patients face significant challenges in accessing these medicines including high rates of
prescription abandonment, non-adherence, and early discontinuation.
Integration between health plans and specialty pharmacies may also impact patients using oral
oncolytics. Indeed, many health plans have acquired a specialty pharmacy. This includes Centene and
AcariaHealth (2013), CVS and Aetna (2018), Cigna and Accredo Pharmacy (2018), and Anthem and Bioplus
(2022). Similarly, UnitedHealthcare has long been integrated with Optum Specialty Pharmacy, but has also
recently acquired Avella (2018) and Diplomat (2019). Humana has long been integrated with Humana
Specialty Pharmacy. Yet, the implications for patients are unclear. On the one hand, plan-pharmacy integration
may allow plans to better assure patients receive and are adhering to medications, especially when it may
reduce other forms of avoidable costs. On the other hand, plan-pharmacy integration may harm patients if it
reduces the pharmacy’s incentive to assure access, as utilization poses a direct cost to the parent company.
We propose describing and studying the effects of health plan and specialty pharmacy integration in
cancer care. We will first build a unique longitudinal dataset identifying the pharmacies owned by each health
insurer carrier in each year between 2010 and 2021. We will then seek to accomplish the following aims:
1. Describe trends in the degree to which oral oncolytics are filled through health plan-integrated pharmacies
2. Evaluate the association between health plan-pharmacy integration and patient outcomes including time-
to-fill and medication adherence for oral oncolytics
This proposal is closely related to the parent R01 and policy in two ways. First, this project studies a
novel form of integration that has gone understudied: integration between health plans and pharmacies. This
form of integration is also highly relevant for anti-trust policy, as the Federal Trade Commission is interested in
crafting policy related to integration between plans, pharmacy benefit managers, and pharmacies. Second, the
project focuses on a key policy lever, namely health plan policy, that influences quality and access to care.

Public health relevance
Project Narrative/Relevance This study will examine changes in health plan ownership of specialty pharmacies over time and the impact of these changes on access and quality of care for cancer patients using oral cancer drugs. These findings will provide oncology practitioners, payers, and policymakers valuable information to improve access, quality and outcomes of cancer care. Our results also will be especially informative to policymakers in crafting an appropriate policy response to growing integration between plans and pharmacies.